Uncovering the Function and Protein Subcellular Localization of Bicistronic Loci in Auxenochlorella protothecoides

Project Summary
Polycistronic expression is the production of two or more polypeptides from one mRNA. It has historically been
assumed that eukaryotic mRNAs are monocistronic. However, applications of advancements in sequencing
technology have revealed a growing number of nucleus-encoded polycistronic genes previously undetected in
eukaryotic genomes, including hundreds of polycistronic transcripts in the green algal lineage, discovered by the
sponsor. The polycistronic arrangement of these genes is conserved over half a billion years of evolution in the
green algal radiation, and the proteins encoded by these loci are conserved throughout eukaryotes, including
humans. In previous work, the applicant addressed the question of the mechanism of translation of two proteins
from a single RNA, and concluded, based on bioinformatic analysis and experimental tests, that leaky ribosome
scanning was the most likely mechanism. Now, the applicant will address the actual function of the proteins
encoded by two polycistronic loci. In some cases, where the function of the locus is known, the two proteins
function together in the same pathway. Nevertheless, in many cases the proteins’ function is unknown, which
offers the applicant an opportunity for discovery. In Aim 1, the applicant will use facile gene replacement
methodology, developed for the green alga Auxenochlorella protothecoides in the sponsor’s laboratory, for
reverse genetic analysis of two polycistronic loci. For each locus, strains carrying individual loss of function ORF1
and ORF2 as well as dual loss of function ORF1+ORF2 strains will be created. The mutants will be compared
to the wild-type for phenotyping, which will involve physiological as well as biochemical assays focused on
bioenergetic and metabolic parameters related to photosynthesis and respiration, located respectively in the
chloroplast and mitochondria. Besides deducing the function(s) of these conserved proteins the work may also
reveal why the proteins remain polycistronic. In parallel, in Aim 2, the applicant will develop fluorescent protein
reporters to mark individual organellar compartments in A. protothecoides, based on well-characterized proteins
and reporter fusions in classic model organisms. These can be used as positive controls for localization of the
ORFs of interest from Aim 1, which can reinforce the deduced function(s). The reporters will also serve as a
community resource for discovery projects or for synthetic biology designs. The sponsor and institution offer the
resources and expertise for executing the proposed research, have programs for and are committed to mentoring
the applicant. The training program includes development of soft skills and adherence to professional standards.
The applicant will receive an intellectual foundation, scientific independence, and a diverse set of skills, all of
which will prepare him to be an exceptional independent investigator.

Public health relevance
Project Narrative Polycistronic genes, previously believed to be uncommon in eukaryotes, were discovered to be widespread in the green algal lineage, with many of these genes encoding both pioneer proteins and proteins predicted to be widely conserved in the eukaryotic lineage. In previous work, I sought to understand how the downstream ORF is translated in eukaryotes in a bicistronic context, and I pinpointed leaky scanning by the ribosome in combination with Kozak sequence strength as the underlying mechanism. Now, I will deduce the function of highly conserved genes in such bicistronic transcripts using a “model” organism suited for reverse genetics by generating loss of function mutant strains and determining the subcellular localization of the proteins with reporter constructs.